Early Pathogenesis of Cystic Fibrosis Related Diabetes

1 Project Summary
2 Cystic Fibrosis (CF) is the most common lethal autosomal recessive disorder in Caucasian populations and is
3 caused by defects in the cystic fibrosis conductance regulator (CFTR) chloride channel. CF is a multi-organ
4 disease affecting the lung, pancreas, liver, intestine, and gallbladder. Cystic fibrosis related diabetes (CFRD) is
5 the most common severe complication of CF and is associated with increased morbidity and mortality. CFRD,
6 which is pathophysiologically distinct from type 1 and type 2 diabetes, significantly worsens the nutritional and
7 pulmonary health of CF patients. Our studies in CF ferrets and children 3 months to 6 years of age suggest that
8 the underpinnings of CFRD occur very early in life when acinar cells are lost and inflammatory/fibrotic remodeling
9 occurs. In CF ferrets, this exocrine-driven pancreatic remodeling leads to a glycemic crisis caused by b-cell loss
10 and/or dysfunction. Interestingly, the emergence of newly formed b-cells in CF ferrets coincides with a transient
11 recovery in glycemic control. Nonetheless, those CF ferrets with the greatest early-life glycemic disturbances go
12 on to develop CFRD later in life. We have also reported that a similar pattern of glycemic disturbance and
13 recovery occurs in young CF children. Our central hypothesis proposes that new b-cells in the CF ferret pancreas
14 are derived from exocrine progenitors and/or committed dedifferentiated b-cells. Three lineage tracing ferret
15 models will be used to fate map b-cell progenitors (INS-IRES-CreERT2), ductal-derived endocrine progenitors
16 (KRT7-IRES-CreERT2), and acinar-derived endocrine progenitors (PTF1A-IRES-CreERT2). The use of an additional
17 CFTRG551D ferret model, which affords temporal control of pancreatic disease onset using the CFTR modulator
18 VX-770, will allow for dissection of how the developmental timing of pancreatitis impact progenitor cell states
19 and longer-term progression of CFRD. Our in vivo and in vitro preliminary data also show that CF ferret ductal
20 cells acquire properties consistent with the transcriptional and epigenetic states found in pancreatic progenitors
21 during development. The mechanisms of this alteration will be investigated by using in vitro models and the study
22 of pancreatic progenitor cell specification during in utero development of the CF ferret pancreas. The proposed
23 research has brought together two institutions with expertise in animal modeling of CF pancreatic disease,
24 lineage-tracing of islet endocrine precursors, and integrated physiology of CFRD to delineate the mechanism of
25 islet resurgence in CF using the first ever non-rodent lineage-tracing models. These studies are expected to
26 identify mechanisms not only relevant to CFRD, but also other forms of pancreatogenic diabetes.

Public health relevance
Project Narrative Cystic Fibrosis (CF) is the most common life-threatening autosomal recessive condition among Caucasians, with over $450 million dollars spent annually on clinical care of CF patients in the U.S. alone. Cystic fibrosis related diabetes (CFRD) is the most common severe complication of CF and is well known to be associated with increased mortality and a decline in lung function. This proposal will characterize early pancreatic remodeling events in CF ferrets that contribute to islet maintenance and impact the development of CFRD, with the long- term goal of translating findings into preventive strategies and treatments for this disease.